Career Development in Cancer Prevention Research at FCCC

DESCRIPTION (provided by applicant): The Population Science Division of the Fox Chase Cancer Center (FCCC) provides a multidisciplinary environment which focuses on cancer prevention and control research; behavioral and psychosocial research; human genetics research; biostatistics research; molecular epidemiology research; carcinogenesis and preclinical biomarker research; and chemoprevention research. This research is concentrated in a three-story 120,000 square foot building (Cancer Prevention Pavilion) dedicated to prevention research on the FCCC campus. The first floor has a waiting area, 16 examination/consultation rooms, three small conference rooms, a patient and family education room, and offices for Behavioral Science investigators and for medical staff involved in the High Risk clinic. The two upper floors contain laboratories and office space for the Carcinogenesis, Human Genetics, Cancer Epidemiology, and Preclinical Chemoprevention Programs plus core support facilities. The purpose of this program is: 1) to train two postdoctoral scientists/year in a multidisciplinary approach to cancer prevention and control research and; 2) to produce well-trained clinical, translational or laboratory investigators who aspire to a career in cancer prevention/population studies research in a comprehensive cancer center. The training includes: 1) a specialized curriculum which introduces all trainees to the principles of cancer prevention; 2) didactic lectures and seminars that emphasize applied clinical and population prevention research; 3) a two-year research project mentored by two or more experienced staff; and 4) completion of an IRB-approved research proposal which can compete for peer-reviewed funding. An Education Advisory Committee will monitor recruitment procedures, provide oversite of the program, certify completion of candidate training, and evaluate effectiveness of the program.